The IMPACT Study: Improving Mentorship Practice through Attributions and Conflict Training

Project Summary
Many students in biomedical graduate programs have negative experiences with their research advisors,
leading to worse well-being and lower success. Further, conflicts with advisors can be worse for biomedical
graduate students from underrepresented backgrounds (e.g., racial and ethnic minorities). Few intervention
programs have examined how to improve student-advisor relationships in an ongoing, sustainable way. The
current proposal aims to develop and test the effectiveness of a research advisor mentorship intervention with
two complementary components: (1) attribution retraining, to encourage advisors to perceive their mentorship
relationships as controllable and malleable in order to motivate them to improve their mentorship, and (2)
conflict skills training, to equip advisors with specific and actionable ways to manage and resolve the inevitable
conflicts that arise in these enduring relationships. A second goal is to examine whether a mentorship training
program can be successful and sustainable with modest time and resource investments, to facilitate scale-up.
Specific study aims are: 1) to develop, pilot test, and refine both light- and heavy-touch versions of a
mentorship attribution retraining + conflict skills training intervention for research advisors; 2) to test the
effectiveness of light-touch and heavy-touch interventions compared to a “no intervention” control group on
mentoring relationship functions and quality as well as graduate students’ program satisfaction, scholarly
productivity, and career intentions; and 3) to determine whether the effectiveness of either intervention is
moderated by graduate students’ gender or membership in an underrepresented group (i.e., racial/ethnic
minority, low socioeconomic status, disability status). To achieve these aims, iterative pilot work will be
conducted to develop light- and heavy-touch versions of intervention materials. Then the effectiveness of both
interventions will be tested by comparing them to a no-intervention control condition using a randomized
experiment with 270 research advisors at a large U.S. research-intensive university. Both interventions will
provide 8 hours of asynchronous content about attribution retraining and conflict skills training (1 hour per
week); those in the heavy-touch condition will also attend a live, weekly 1-hour practice and discussion session
(16 hours total). Advisors and students will be surveyed to assess any effects on the mentoring relationship.
Effects on graduate student short- and long-term outcomes will also be assessed, including their scholarly
productivity (e.g., presentations, publications), career intentions, and program satisfaction. Broadly, the project
will demonstrate whether a novel intervention for research advisors improves graduate mentoring relationships
and outcomes, and whether a light-touch version is sufficient to accomplish this.

Public health relevance
Project Narrative Biomedical research is the backbone of essential advances fueling public health and well-being, but graduate training in biomedical research is plagued by high attrition and deteriorating student well-being. The present research will address a critical source of influence on these issues, particularly among students who are underrepresented in biomedical fields: the mentoring relationships that biomedical graduate students experience with their research advisors. We propose to design and experimentally test the effectiveness of a low-touch and high-touch intervention that equips research advisors with the motivation and conflict management skills needed to improve their mentoring relationships, and examine how these interventions affect mentoring relationships and students’ career-related outcomes.